How Does a Synaptonemal Complex Protein Promote Crossover Recombination and Synapsis?

Project Summary
Our proposed research aims to decipher the molecular mechanisms that underlie homologous chromosome
segregation during reproductive cell formation. Meiosis is the specialized cell division cycle that partitions the
two homologous copies of every chromosome (homologs) to separate daughter nuclei, effectively reducing
chromosome ploidy. Errors in chromosome segregation lead to aneuploid reproductive cells carrying too many
or two few chromosomes. Key to successful homolog segregation is the prior establishment of transient but
stable linkages between replicated chromosomes; for most organisms these links are formed by interhomolog
crossover recombination events, in conjunction with intact sister cohesion.
How crossover events are efficiently generated between every chromosome pair during meiosis remains
poorly understood, but for most organisms it is clear the process involves an exquisite coordination between
large-scale chromosome movements and local DNA repair processes. A conserved multi-protein structure, the
synaptonemal complex (SC), mediates an intimate alignment between homologous partner chromosome axes
and forms the physical context in which DNA repair intermediates undergo maturation. SC has long been
associated with successful crossover recombination, and although our research demonstrated that the SC
structure per se is dispensable for crossing over in S. cerevisiae (budding yeast), we also showed that the SC
structural component, Zip1, has a genetically separable function in promoting crossovers. Our structurefunction
analysis reveals adjacent domains within Zip1 's N terminus that function independently to promote
crossover recombination and SC assembly, potentially through separate but adjacent interactions with the procrossover
E3 SUMO ligase, Zip3, and the SC central element protein complex Ecm11-Gmc2.
Our research over the past two years has i) obtained additional evidence for an intriguing phosphorylationbased
switch mechanism that controls Zip1's crossover and SC assembly activities, ii) revealed noncontiguous
regions of Zip1 that phenocopy one another in a manner that suggests a specific overlapping configuration of
Zip1 within mature SC, iii) discovered Zip1 protects Zip3 from proteosome-mediated degradation, iv) corrected
Zip3's translational start site, and v) developed proximity labeling as a tool to both study interactions between
pro-crossover and SC proteins and to identify new proximity targets of crossover and synapsis proteins.
Experiments proposed in this renewal application support a rich training environment for one doctoral
student and several undergraduates and use a cost-effective organism with powerful molecular genetics
accessible to students at all levels. The proposed Aims build upon recent data and are designed to deepen our
understanding of how Zip1 's N terminus collaborates with other factors, particularly the Zip3 SUMO ligase, to
promote crossover recombination, and how Zip1 's pro-crossover activity is properly coordinated with and
coupled to assembly of the supramolecular SC structure, which also requires Zip1 as a building block.

Public health relevance
Narrative Over 10% of clinically recognized human pregnancies are aneuploid, a result of errors in homologous chromosome (homolog) segregation during meiosis. Homolog segregation relies on the prior establishment of pairwise associations between partner chromosomes, which are provided by DNA reciprocal exchange events (crossovers). Crossovers take place within the context of a prominent supramolecular chromosomal structure called synaptonemal complex (SC), which facilitates even larger-scale chromosome reorganization; our research seeks to define the molecular mechanisms that promote DNA exchange during meiosis and that coordinate crossover recombination events with SC assembly along the length of aligned homolog pairs.